New animal model for late-onset Fuchs endothelial corneal dystrophy

ABSTRACT
Fuchs’ endothelial corneal dystrophy (FECD) is an inherited corneal disease leading to blindness. Loss of
corneal endothelial cells and guttae (bumps in Descemet’s membrane) are pathological FECD features. A
deficiency of corneal endothelial cells (CEC) causes corneal opacity due to loss of pumping function. In
developed countries, including the U.S., FECD prevalence is estimated to be 4%. Corneal transplantation is the
only treatment for advanced FECD patients. Although corneal transplantation is highly successful, the shortage
of donor corneas makes pharmacologic therapies for FECD an unmet medical need, yet the lack of animal
models for late-onset FECD (which accounts for a majority of cases) has hampered the development of new
therapies. In this project, we will develop new animal models for late-onset FECD. Recent genomic analyses of
patients’ DNA have demonstrated expansion of (CTG)n trinucleotide repeats in the intron of the TCF4 gene. In
Caucasian populations, nearly 80% of late-onset FECD patients have long (CTG)n (n>30-40) repeats, and the
length of (CTG)n is the most predictable genetic mutation for late-onset FECD. Nevertheless, the mechanism of
how the long (CTG)n repeats lead to FECD is unknown. One hypothesis is that long (CUG)n RNA sequesters
RNA splicing factors that lead to alteration of RNA splicing and malfunction of CECs. The other hypothesis is
that the long (CTG)n repeat induces alteration of TCF4 gene expression that leads to the malfunction of CECs.
From various reports and evidence, we hypothesize that long (CUG)n repeat RNA induces the FECD phenotype
independent of the TCF4 gene. To prove this, we will produce two different FECD mouse models. In Aim 1, we
will overexpress long (CUG)n RNA in the corneal endothelium using (CTG)960 mice. The (CTG)960 mice were
initially developed and used as a model for myotonic dystrophy 1 and express long (CUG)960 trinucleotide RNA
under a tetO (tetracycline operator) promoter using three different strategies. In Aim 2, we will overexpress long
(CUG)n RNA in corneal endothelium exogenously by adenovirus, a model that could be applicable to larger
animals relevant to humans. We will monitor in vivo CEC density using a Rostock microscope and in vivo corneal
thickness by corneal optical coherence tomography for up to 10 months. Also, ex vivo corneas will be used to
evaluate (CUG)n RNA accumulation by in situ hybridization, measurement of CEC density by Alizarin red
staining, and observation of CEC ultrastructure by plasma-focused ion beam scanning electron microscope.
When established, our animal models will be useful not only for therapy development but also for understanding
early events in the development of late-onset FECD, such as guttae formation and alteration of mRNA
expression. These studies will determine the relationship of TCF4 to late-onset FECD, elucidate the pathogenic
mechanisms, and create animal models beneficial for therapeutic development.

Public health relevance
NARRATIVE Fuchs’ dystrophy is characterized by the destruction of the corneal endothelium due to genetic defects and is currently treatable only by corneal transplantation. As there are currently no models to study this disease, we will develop animal models of late-onset Fuchs’ dystrophy (the most common form). These animal models will enable research into the causes and treatments for late-onset Fuchs’ dystrophy.